Thyroid Hormone Inhibits Medulloblastoma Growth by Inducing Tumor Cell Differentiation

Project Summary/Abstract
Medulloblastoma (MB) is the most common malignant brain tumor in children. Despite conventional treatment
including surgery, chemotherapy and radiation, a significant proportion of MB patients still succumbs to this
disease. Moreover, almost all patients suffer long-term side effects of the aggressive treatment, such as hearing
loss and cognitive deficit. Improved strategies to treat MB are urgently needed.
Thyroid hormone (TH) plays an important role in normal brain development, but the possible function of TH in
MB pathogenesis is still unknown. Our recent studies revealed an unanticipated link between TH signaling and
MB pathogenesis, with exciting therapeutic implications for MB treatment. In our preliminary studies, we found
that TH induces the expression of NeuroD1, a helix-loop-helix transcription factor in MB cells and stimulates the
terminal differentiation of tumor cells. Upon their differentiation, MB cells lose their tumorigenic potential and
secrete glutamate interfering with the survival of surrounding MB cells. TH-induced differentiation inhibits MB
cell proliferation, and represses MB growth in vivo. Based on these observations, we hypothesize that TH
suppresses MB pathogenesis through inducing tumor cell differentiation. This hypothesis will be tested in three
specific aims: 1) examine how TH promotes MB cell differentiation; 2) examine how tumor cell differentiation
represses MB pathogenicity; 3) test if TH signaling can be exploited for MB therapy.
Our studies will elucidate the mechanisms underlying terminal differentiation of MB cells, and establish an
unprecedented association between TH and MB progression, which will pave the way for TH as a new
therapeutic modality for MB.

Public health relevance
Project Narrative Medulloblastoma is the most common malignant brain tumor, and effective approaches for medulloblastoma treatment are urgently needed. Our preliminary studies revealed that thyroid hormone can induce maturation of medulloblastoma tumor cells, thereby inhibiting tumor growth. In our proposed studies, we will elucidate the mechanism underlying medulloblastoma tumor cell maturation and test the therapeutic potentials of thyroid hormone to treat medulloblastoma.